CONTRACT NO.: HHSN273201600002I - CLINICAL RESEARCH SUPPORT SERVICES FOR NIEHS

This Task Order shall specifically provide support for the annual Women’s Health Awareness Day event, health literacy programs, webinars, conferences, workshops, meetings, health
communications, manuscripts, abstracts, data presentations, and other research activities as necessary.